Unpacking the Importance of the Structural Injuries of MTBI

PROJECT SUMMARY Mild Traumatic Brain Injury (MTBI) is a major public health problem with U.S. annual incidence of over 2 million. We propose to use an innovative paradigm in bicompartment diffusion MRI model parameter estimation to study the dynamic longitudinal microstructural changes that occur after MTBI and to investigate the link between white matter injury, cortical volume loss and cognitive outcome. Our preliminary findings suggest diffusion-based biophysical parameters of axon integrity including intra-axonal diffusivity (Da) and axonal water fraction (f) can detect microstructure changes in MTBI and provide more biophysically relevant information compared with traditional, empirical measures of Diffusion Tensor Imaging (DTI). We will employ a rotationally invariant formalism and parameter estimation scheme for the so-called “Standard Model” of diffusion in white matter which unifies previous attempts of multi-compartment white matter modeling over the past decade, now a widely accepted benchmark for multi-compartment modeling of diffusion in the brain. We will further incorporate spherical tensor encoding (STE) to increase the precision in axon-specific microstructure parameters central to this project and use an optimized and clinically feasible protocol for this translational project. The proposed work is expected to bridge the gap between macroscopic and microstructural alterations relevant to cognitive status after injury, revealing the dynamic structural changes occurring after injury and pointing to imaging biomarkers most relevant to cognitive outcome. The results of this work are expected to be significant from both scientific and clinical perspectives by 1) advancing basic knowledge of injury in an impactful way, 2) discovering biophysically meaningful imaging biomarkers relevant to cognitive status in MTBI, and 3) mechanistically linking microstructural and macrostructural brain alterations, in three respective specific aims. This will provide a means toward quantitative tracking of injury and recovery in the cognitive domain, and tracking of efficacy of targeted cognitive therapeutic strategies such as cognitive rehabilitation and integrated behavioral health treatment in patients with MTBI.

Public health relevance
PROJECT NARRATIVE Mild Traumatic Brain Injury (MTBI) is a major public health problem with U.S. annual incidence of over 2 million yet the underlying pathology remains unclear and clinicians cannot identify those who will have prolonged symptoms. This proposal aims to employ innovative MRI techniques to study microstructural and macrostructural injury as they relate to cognitive symptoms in MTBI patients, translating promising evidence from cell and animal studies to a clinical MTBI population. The results of this investigation are expected to establish the dynamic longitudinal microstructural changes that occur after MTBI, investigating the link between white matter injury, cortical volume loss and cognitive outcomes.